Nannocystin Reagents to Elucidate the Role of Elongation Factor 1a in Apoptosis

Project Summary
Nannocystin reagents will be used to interrogate the role of the protein elongation factor 1A in apoptosis of
cancer cells. Nannocystins are small molecule natural products isolated from myxobacteria that potently inhibit
cancer cell proliferation and trigger apoptosis at an early time point. Nannocystin is a hybrid molecule consisting
of an upper tripeptide domain and a lower polyketide domain. Nannocystin binds the protein eukaryotic
elongation factor 1α (EEF1A), however it is presently unclear how binding to this protein causes apoptosis. The
related molecule didemnin B also binds EEF1A, inhibiting EEF1A-mediated elongation at micromolar
concentrations but triggering apoptosis at nanomolar concentrations. Elongation factors are vital for protein
synthesis, but additional cellular roles have recently been found. In particular, EEF1A was found to inhibit p53's
activity as a tumor suppressor, and cancer cells under stress increase EEF1A production. It is hypothesized that
nannocystin disrupts EEF1A-p53 binding, which releases p53 to activate the apoptosis pathway, leading to cell
death. Nannocystin is thought to bind EEF1A at the same site as didemnin B. However, there are no cocrystal
structures of EEF1A-nannocystin, and a recent structure-activity relationship study challenged this putative
binding model. Details of the binding site are critical for rational development of new anticancer therapeutics
related to nannocystin. To investigate apoptosis in cancer cells, we propose studies in which nannocystin and
molecular probe reagents will be prepared by total synthesis, an approach that requires efficient and convergent
chemical synthesis. We will also employ a tandem reaction between a simple alkene and alkyne to access the
unique polyketide domain. This proposal has three specific aims: (1) to use Ru coupling and Co-promoted
isomerization in the total synthesis of nannocystin, for which we have made significant progress toward both the
tripeptide and polyketide fragments; (2) to synthesize two bifunctional photoaffinity reagents to elucidate the site
of binding between nannocystin and EEF1A, incorporating a novel tripeptide to introduce the photoaffinity probe,
designed to covalently bond to the protein at the two extreme ends of the binding site; and (3) to determine if the
p53 pathway is involved in nannocystin-triggered apoptosis and identify the downstream effectors of p53
activation.

Public health relevance
Project Narrative The total synthesis of the eukaryotic elongation factor 1α (EEF1A)-binding small-molecule nannocystin will enable the preparation of nannocystin reagents to study apoptosis signaling in cancer cells. EEF1A, though important for protein synthesis, also has noncanonical roles, such as binding to and regulating p53. It is hypothesized that nannocystin binds to EEF1A, disrupts p53 binding, and triggers apoptosis.